Type I interferons in tolerance in the steady state

Summary
Type I interferons are a powerful cytokine family that play an essential role in innate immune protection from
viruses. In addition to their direct anti-viral activities, they strongly activate multiple cells of the adaptive
immune system, including APC, B cells, and T cells. Interestingly, interferons are expressed in the thymus in
the steady state, in the absence of infections. In this project, we propose to systematically define the role that
thymic type I interferon plays in immunological self-tolerance. We hypothesize that type I interferons are critical
to promote tolerance to self-epitopes that are usually only displayed during infections. Aim 1 will determine
what stimuli promote thymic medullary epithelial cells to produce IFNb. Aim 2 will determine the consequences
of IFNb expression on tolerance to conventional and inflammation induced self antigens. Aim 3 will determine
if autoimmunity results in the absence of thymic IFNb, particularly when mice are challenged by infections.